Building a data science workforce to improve the reproducibility of rehabilitation research

PROJECT SUMMARY
Data science methods provide an exciting opportunity to significantly improve the reproducibility and
replicability of rehabilitation research. However, a key barrier to implementing data science methods in
rehabilitation research is a lack of fundamental programming knowledge. In particular, many clinical and basic
scientists have not received formal training in programming skills required for data science. For this target
audience, the most efficient way to get started in data science is to receive personalized guidance from an
experienced mentor who can provide hands-on assistance and identify which skills are the most beneficial given
a specific research goal. However, many rehabilitation researchers do not have access to these types of mentors.
The proposed program (Reproducible Rehabilitation, or ReproRehab) addresses this need by providing
personalized, rehabilitation-specific, hands-on training in data science skills with direct, weekly support
from experienced mentors. The ReproRehab program will blend hands-on assistance, personalized
mentorship, and a uniquely rehabilitation-focused curation of online resources for self-guided learning, with three
specific aims. Aim 1 is to build a national workforce of rehabilitation researchers equipped to apply data
science skills to their own rehabilitation research. To accomplish this Aim, over the 5-year grant a total of
100 learners will undergo a personalized, 6-month program consisting of a 2-month TA-guided, hands-on
bootcamp in which learners are assigned to small groups with similar research needs, followed by a 4-month
self-guided learning segment to integrate the skills into their own research. By the end of the program, learners
will demonstrate the implementation of this knowledge into their own research, including but not limited to the
sharing of open-source rehabilitation datasets, open-source analysis code or methods, and more rigorous
research products. Aim 2 is to develop data science rehabilitation researchers who have the capacity to
teach and train others. To accomplish this Aim, over the grant’s 5 years a total of 40 TAs will refine their
teaching skills by administering bootcamps and providing hands-on training to learners. In addition, while the
learners pursue self-guided learning, TAs will develop and host their own bootcamps in their rehabilitation
communities, thereby fulfilling a train-the-trainer model for exponential growth and dissemination of data science
skills. Aim 3 is to broadly disseminate knowledge by creating an online repository of curated,
rehabilitation-specific data science resources, organized by rehabilitation research area, including
program materials. To accomplish this Aim, the leadership team will develop a public web database of existing
online data science resources, including training materials, public data archives, and all course materials from
this program, organized by specific rehabilitation research areas and needs. Successful accomplishment of
our aims will increase capacity in data science across the rehabilitation research community and will
improve the rigor, reproducibility and replicability of research needed to move the field forward.

Public health relevance
PROJECT NARRATIVE Data science methods provide an exciting opportunity to significantly improve the rigor of rehabilitation research by increasing the reproducibility and replicability of research. Data science methods, which rely on computer programming skills for data intake, management, storage, and analysis, can increase reproducibility, but clinical and basic rehabilitation researchers may have challenges adopting these practices due to a lack fundamental training in computer programming. The proposed Reproducible Rehabilitation (ReproRehab) research education program will build a sustainable national workforce of rehabilitation researchers equipped with basic data science skills by: (1) implementing an innovative, hands-on bootcamp for rehabilitation researchers to learn beginning data science skills and integrate them into their own research, (2) employing a train-the-trainer model to rapidly increase capacity for data science and training of data science in the rehabilitation research community, and (3) broadly disseminating data science resources curated specifically for rehabilitation researchers through a publicly accessible web portal.